Precision Identification and Targeting of Rod Microglia in Diffuse Brain-Injured Cortex

PROJECT SUMMARY:
After experimental diffuse traumatic brain injury (TBI), we rediscovered the rod microglia – a morphological
variant of activated microglia in the pathology or repair of the brain. Rod microglia are depicted in the drawings
of Nissl, Cajal, and del Rio Hortega in cases of general paresis, but were largely ignored for around 100 years.
Rod microglia have recently been visualized in human Alzheimer’s disease, Autism spectrum disorder and
experimental models of TBI, bacterial infection, and seizure, but no function has been reported.
We reproducibly observe rod microglia that align in trains across cortical layers adjacent to neuronal processes
in foci of neuropathology after diffuse TBI and they form and recede in a time course consistent with
neuropathology. Yet, advanced molecular tools are absent from the arsenal necessary to understand rod
microglia structure and function. We hypothesize that rod microglia have a unique molecular profile compared
to other microglia morphologies, which provide tools to confirm rod microglia mechanisms in diffuse TBI.
To investigate the significance and impact of rod microglia in diffuse TBI, the current proposal will provide critical
data to distinguish rod microglia from activated and ramified microglia by molecular profile using phage display
biopanning and RNA sequencing. We will induce diffuse TBI by midline fluid percussion injury in adult male and
female CX3Cr1-eGFP mice and identify rod microglia based on morphology. Laser capture microdissection will
isolate rod microglia and non-rod microglia (activated and ramified) from cortical regions. Isolated cells in aim 1
will be used for phage display biopanning to develop and validate a cell surface marker unique to rod microglia.
Isolated cells in aim 2 will be used for next-generation sequencing (RNAseq) to reveal upregulated gene
expression in rod microglia compared to activated and ramified morphologies. Pathway analysis will be
incorporated to identify unique expression domains associated with the function and origin of rod microglia. The
sponsor and mentoring team provide collective experience and expertise to provide advanced training for the
applicant to achieve the aims. Data from this proposal will define the molecular profile of rod microglia and result
in developed tools for quantitative and isolation protocols of rod microglia. With refined molecular tools, rod
microglia can be investigated across neurological conditions (e.g. Alzheimer’s disease, Autism spectrum
disorder, seizure) and activated or inhibited to drive treatment of neurological symptoms.

Public health relevance
Neurological insults, such as traumatic brain injury, trigger inflammation signaling that go on to activate microglial cells. In this proposal, we investigate lesser-known microglia subtype, the rod microglia, to determine cell surface markers and gene expression unique to their occurrence after diffuse traumatic brain injury. These rod microglia markers could serve as biomarkers in the diagnosis and prognosis of injury and recovery from neurological conditions.